PASK-regulated genes and proteins as therapeutic targets for ALS and FTD

Project Summary/Abstract
Regulation of autophagy and the nutrient-sensing kinases mTOR and AMPK are not only important in cancer,
but have garnered much recent attention in neurodegeneration. The Per–Arnt–Sim domain kinase (PASK)
function both up- and downstream of mTOR. Our studies in spinocerebellar ataxia type 2 (SCA2) revealed that
PASK is overabundant upon ATXN2 mutation. In yeast, Pask directly phosphorylates the ATXN2 homolog
Prp1. This was an intriguing connection to our work as we had previously found that mTOR is dysregulated
upon ATXN2 mutation. Our preliminary data support a feedforward control mechanism of PASK in SCA2.
When ATXN2 is mutated, PASK levels rise further limiting autophagy. In our previous work we showed that
STAU1 is also elevated with ATXN2 mutation leading to enhanced translation of mTOR mRNA, which in turn is
known to activate PASK. In preliminary data we have shown that targeting PASK by RNAi or with the PASK-
specific inhibitor BioE-115 in cultured cells, or genetically in SCA2 mice significantly reduced STAU1 protein
levels, improved autophagic flux and levels of Purkinje cell marker proteins, effectively mimicking ASO
knockdown of ATXN2. We hypothesize that the kinase activity of PASK regulates activity in the ATXN2 –
STAU1 pathway modulating TDP-43 pathology. We further hypothesize that that targeting PASK is an effective
way to normalizing TDP-43 proteinopathy, including amyotrophic lateral sclerosis (ALS) / frontotemporal
dementia (FTD) and the Alzheimer’s disease-like dementia disorder limbic age related TDP-43 encephalopathy
(LATE). The overall objective of our study is to understand PASK in neurodegeneration and to generate proof-
of-concept for targeting PASK for treating SCA2 and TDP-43 proteinopathies to support future therapeutic
development. Three specific aims are proposed: In Aim 1 we will use a proteomic approach to identify
phosphorylated peptides of the ATXN2 protein. We will also investigate isogenic SCA2 and TDP43 mutant
patient iPSC cortical neurons to produce transcriptome and proteomic analysis to identify differentially
regulated genes, proteins and pathways dependent on BioE-1115. In Aim 2 we perform two genetic interaction
studies to demonstrate modification of motor and molecular autopagy phenotypes in SCA2 (ATXN2-Q127) and
Prp-TDP43-Q331K transgenic mice haploinsufficient for Pask. In Aim 3 we will demonstrate modification of
molecular phenotypes of Prp-TDP43-Q331K mice treated with BioE-1115, and also conduct a proof-of-concept
study showing effectiveness of an ASO targeting Pask in modification of both motor and molecular phenotypes
of Prp-TDP43-Q331K mice. Our expectation is to demonstrate that ATXN2 is phosphorylated, that its
phosphorylation is modulated by BioE-1115, and to demonstrate PASK as a therapeutic target for SCA2, ALS,
FTD and possibly other AD/ADRDs.

Public health relevance
Project Narrative Neurodegenerative diseases are imposing an increasing health and financial burden given the rapid increase of the aging segment of the population. This grant will use a multidisciplinary approach to characterize PAS kinase as a new novel target for therapy of spinocerebellar ataxias, amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD). Our approaches will likely have a broad impact on other neurodegenerative diseases as well.